Interplay of the HIV-1 Env cytoplasmic tail, Gag-MA, and membrane: resolving molecular detail and blocking assembly

PROJECT SUMMARY/ABSTRACT
The goal of this innovative project is to bring together multidisciplinary expertise to dissect the functional,
structural, and dynamic nature of interactions between the HIV-1 envelope (Env) cytoplasmic tail (CT), the
underlying Gag matrix (MA) lattice, and the lipid containing membrane in the context of native virions. We will
utilize state-of-the-art cryo-electron tomography (cryo-ET), molecular dynamics (MD) simulations, modeling, and
in vitro studies to produce a comprehensive rendition of how interactions between these key determinants of
assembly and infectivity are orchestrated. Our studies are based on recent cryo-ET data in which the positioning
of Env CT and MA interactions differed from previous models. In Aim 1, we will harness the power of cryo-ET to
advance the resolution of Env CT-MA interactions to facilitate further interrogation of the mechanics of Env CT-
MA-membrane interactions. In Aim 2, we will generate atomistic models of Env CT-MA in the context of the viral
membrane using high resolution structures and cryo-ET density, and strategic mutations and truncations of Env
CT and MA. In Aim 3, we will exploit conserved structural features to design novel antiviral agents comprised of
membrane-permeable cyclic peptide inhibitors. These Aims are supported by comprehensive biochemical and
virologic approaches and will use a well characterized clade C transmitted/founder (T/F) HIV-1 infectious
molecular clone that is fully representative of global isolates and presents fully matched Env and Gag
components, which distinguishes our work. Our studies will reveal in unprecedented detail how Env CT, MA, and
membrane lipids engage one another, with all components in near native context. These powerful approaches
will produce an integrated model, including flexible regions that are difficult to resolve, to bring the complete Env-
MA-membrane machinery to life.

Public health relevance
PROJECT NARRATIVE HIV-1 contains multiple essential components including conserved targets that may be amenable to drug design. Our understanding of HIV structure and how it incorporates its envelope protein has been mostly limited to studies of components in isolation. Here, we will combine cutting edge structural, computational, biochemical, and virologic approaches to reveal how key components interact in a native context within HIV intact virus particles and develop new drugs to block these crucial interactions.